Predictive Markers of Response to and Treatment Effects of Motixafortide, Cemiplimab, Gemcitabine and Nab-Paclitaxel in Treatment Naïve Metastatic Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Combination chemotherapy is the standard of care in treatment-naïve metastatic pancreatic adenocarcinoma
(mPDA), and the addition of immune checkpoint blockade has failed to improve outcomes. The C-X-C motif
chemokine receptor 4 (CXCR4)/C-X-C motif chemokine ligand 12 (CXCL12) axis contributes to the exclusion
of anti-tumor immune cells from the tumor microenvironment (TME) in mPDA. We recently conducted a phase
I study of motixafortide (CXCR4 inhibitor), cemiplimab (anti-PD1), gemcitabine and nab-paclitaxel (MCGN) in
11 patients with treatment-naïve mPDA, demonstrating promising, durable clinical efficacy with an objective
response rate of 64% (7/11). Using single nucleus RNA sequencing (snRNAseq) analyses of pre-treatment
biopsy samples, we demonstrated that CXCL12-producing cancer associated fibroblasts (CAFs) were more
abundant in patients with a better response to therapy. These CXCL12-producing CAFs belonged to a CAF
subtype displaying a ‘pro-axonogenic’ gene expression signature, enriched in axon guidance and axonogenic
programs.
We are now conducting a phase II, investigator-initiated, multicenter, randomized controlled trial (RCT) to
evaluate this novel immunotherapeutic approach. This trial compares MCGN (N=72) with gemcitabine and
nab-paclitaxel (GN, N=36) in treatment-naïve mPDA. The primary endpoint of the trial is progression free
survival and secondary endpoints include response rate, disease control rate, duration of clinical benefit and
overall survival.
We also seek mechanistic insight into response and resistance to these novel therapies. All patients will
undergo pre-treatment biopsies which will be analyzed using quantitative multiplex immunofluorescence (qmIF)
to categorize the abundance and spatial relationships of CAF, tumor and immune cell populations. This panel
will categorize CXCL12-producing pro-axonogenic CAF populations, the drivers of CXCR4/CXCL12 pathway-
mediated immunosuppression, to validate their abundance as a potential marker of preferential benefit from
MCGN.
A subset of patients in each arm of this trial will undergo on-treatment biopsies which will be used to
characterize the impact of MCGN (N=21) and GN (N=10) on the TME. qmIF and snRNAseq will be performed
on paired pre- and on-treatment biopsy specimens. The goal of this investigation is to evaluate for mechanisms
of response and resistance. GN is one of the most commonly used regimens in mPDA, but its impact on the
TME has not been evaluated prospectively. This study could lead to a better understanding of response and
resistance mechanisms to GN and lead to promising therapeutic combinations. We hope to elucidate why
immunotherapy has so far been ineffective in mPDA and whether there are patients for whom adding PD1 and
CXCR4 inhibition to chemotherapy can improve outcomes.

Public health relevance
PROJECT NARRATIVE Metastatic pancreatic cancer is a devastating malignancy with a median survival of under a year. Adding two immunotherapy agents, motixafortide and cemiplimab, to standard of care chemotherapy with gemcitabine and nab-paclitaxel showed clinical efficacy in a phase I clinical trial. This project will evaluate the efficacy of this combination in a randomized clinical trial, identify subsets of patients most likely to benefit and evaluate the impact of this combination and standard of care chemotherapy on the tumor microenvironment.